MYCN drives a ferroptotic vulnerability in neuroblastoma

Project Summary: Apoptosis is a type of programmed cell death and has for a long time been appreciated to
be a hallmark of cancer cells. In recent years, drugs targeting the apoptotic pathway, such as the FDA-
approved BCL-2 inhibitor, venetoclax, have revolutionized therapy in cancers which have a particular
vulnerability to targeting this pathway. A different programmed cell death pathway, ferroptosis, has recently
been discovered. Understanding which cancers may be vulnerable to the induction of ferroptosis and which
targetable molecules are involved could lead to a new wave of successful cancer therapy. MYCN-amplified
neuroblastoma (NB) is one of the deadliest subtypes of pediatric cancer. Here in, we demonstrate that
amplified MYCN drives an aberrant iron capture program in NB and increases intracellular cysteine
biosynthesis and selenocysteine dependence through multiple mechanisms to detoxify reactive oxygen
species (ROS) accumulation as a result of high cellular iron. The consequence of these MYCN-directed
changes is a synthetic lethality to genetic or pharmaceutical targeting of the glutathione/glutathione peroxidase
4 (GPX4) pathway resulting in ferroptotic cell death. This grant aims to expand our understanding of how
MYCN alters cysteine and selenocysteine production and ferroptotic inducing pathways to sustain an
antioxidant defense and how these pathways may be exploited pharmaceutically to improve therapeutic
responses in this recalcitrant tumor type.
Specific Aims:
Aim 1: Characterize the ability of MYCN to suppress ferroptosis in neuroblastoma
Aim 2: Identification of synthetic lethal ferroptosis resistance mechanisms in MYCN-amplified neuroblastoma
Aim 3: In MYCN-amplified neuroblastoma mouse models, evaluate novel ferroptotic combination therapies
Study Design: Using well characterized isogenic cell lines and patient-derived xenograft cell cultures, we will
mobilize expertise in selenocysteine biosynthesis (Copeland), pantothenate kinase inhibitors (Rock), and
genomic screening of ferroptotic pathway modifiers (Olzmann) to better define the ferroptotic vulnerability in
MYCN-amplified NB and to uncover novel sensitizers to ferroptotic inducers in MYCN-amplified NB. The goal
of these experiments is to not only better understand how the MYCN oncogene hijacks cysteine for
selenocysteine production to mount a defense against an oxidized phenotype, but to create new therapeutics
to create better anti-ferroptotic approaches in MYCN-amplified NB. To this end, we will work with our preclinical
mouse model expert (Koblinski) and a NB clinical investigator (Glod) to build the preclinical evidence of
synthetic lethal new therapies into the clinic for refractory NB patients.

Public health relevance
Project Narrative The oncogenic transcription factor MYCN drives a subset of neuroblastoma tumors which is deadly in half the cases despite protracted and intense therapy including polychemotherapy and immunotherapy (anti-GD2 therapy). As MYCN remains undruggable, finding synthetic lethal relationships that may result in new treatments is one of the “holy grails” of pediatric cancer therapy. In this grant proposal, we provide evidence that amplified MYCN orchestrates a complex and intricate re-wiring of the neuroblastoma cell to 1) increase iron metabolism, 2) increase cysteine and selenocysteine biosynthesis to counteract reactive oxygen species created from iron metabolism-related Fenton reactions and 3) increase synthesis of pantothenate kinase 3 (PANK3) to subsequently increase coA levels; the result of which is the creation of a synthetic lethality and therapeutic vulnerability to ferroptosis induction which we aim to explore, clarify and translate to new therapeutic options for this recalcitrant pediatric tumor.